Lymphedema therapy via lymphatic targeted drug delivery

PROJECT SUMMARY
Lymphedema, which results from the failure of the lymphatic system to properly drain fluid, proteins, lipids, and
immune cells from the interstitium of the skin, leads to irreversible tissue remodeling including fibrosis, swelling,
and lipid accumulation. It occurs most commonly in the US as a result of cancer treatment. In breast cancer
almost 1 in 3 survivors develop lymphedema and the presence has persisted in spite of reductions to the
aggressiveness of cancer therapy achieved through sentinel lymph node biopsy. Being diagnosed with
lymphedema remains a life sentence as there is no cure. In this project, a new therapeutic paradigm for treating
lymphedema will be explored using pre-clinical models of surgically induced disease.
The objective of this program is to further develop and optimize a lymphatic-targeting sustained drug delivery
system for lymphedema therapy. Different types of lymphatic pump function modulators [L-type calcium channel
activator and potassium channel blocker] and two classes of immunomodulators that ameliorate lymphedema-
induced inflammation [inhibitors of calcineurin and transforming growth factor beta], and synergies in improving
the benefits of vascularized lymph node transfer will be tested. The single vessel ligation mouse model of
lymphedema will be used as, in contrast to genetic models, it is not plagued by transgene-associated immune
deficiencies and closely resembles the pathophysiology of human disease. Utilizing unique dual-wavelength
near infrared imaging capabilities, lymphatic function and drug biodistribution over disease progression and
therapy will be tracked. This will be achieved through three specific aims: Aim 1 will focus on lymphatic delivery
and effects of drugs restoring lymphatic pump function. Aim 2 will harness methods of sustained delivery into
locoregional tissues as well as lymphatic delivery to lymph nodes to determine the effects of immune modulatory
cargos on the immune cell populations within the draining lymph node, the resulting pathology in the
lymphedematous tissue, and the consequences to lymphatic function. Aim 3 will investigate the combined
delivery of lymphatic function bolstering or immune modulatory agents in a model of chronic lymphedema and
synergies in combination with vascular lymph node transplant, the only existing investigational surgical
intervention for lymphedema. The expected outcome of this project is a therapeutic regime for improving
lymphatic function in the treatment of lymphedema, replacing watch-and-wait philosophy with low-dose (but
focused) drugs that support lymphatic transport functions.

Public health relevance
PROJECT NARRATIVE The lymphatic vasculature provides crucial functions for the maintenance of homeostasis in a variety of tissues and organs by providing the primary route through which immune cells, large proteins, lipids, and interstitial fluid are returned to the blood circulation. This proposed work seeks to utilize drug delivery strategies to 1) enhance lymphatic pumping via pharmacologic modulation of ion channels within the lymphatic muscle of the intact vasculature and 2) reduce the local inflammation through targeted immunomodulator delivery locally and to the lymph node downstream of the site of lymphedema. Findings from this work will lead to a new class of therapeutic strategies for regional enhancement of lymphatic pump function and reducing inflammation in lymphedema.